Characterizing the evolutionary architecture of complex disease within and across diverse populations

The past decade of genome-wide association studies (GWASs) has seen thousands of complex traits and diseases studied and identified thousands of reproducibly associated genetic variants. GWAS has helped characterize the complexity of common genetic architectures and shed light on the role of genetics in disease risk. A large body of works have demonstrated that risks of complex traits are highly enriched in functional regions of the genome, which indicates that risk is mediated through perturbed regulatory action on relevant susceptibility genes. Similarly, multiple recent works have found that disease risks are shaped by forces of natural selection, which kept the frequencies of deleterious alleles low in the population. Together, the functional mechanisms and their interplay with natural selection can be coupled under a general mechanism we refer to as the evolutionary architecture. Current frameworks to infer the evolutionary architecture for common complex diseases are only applicable to relatively homogenous populations. Several recent works have demonstrated that integrating multi-population GWAS data substantially improves statistical power to identify causal factors underlying complex traits and diseases due to the increased heterogeneity in allele frequencies. Current approaches evolutionary architecture are unable to appropriately model the heterogeneity across populations with respect to allele frequencies and linkage disequilibrium. Similarly, the resolution of these methods is currently limited to complex diseases and phenotypes, whose inferred architectures, while informative, fail to describe regulatory network mechanisms that mediate risk. Methods capable of analyzing many molecular phenotypes simultaneously have the potential to identify shared architectures, and pinpoint core genes relevant for disease risk. Lastly, several works have shown that integrating functional information with GWAS substantially improves polygenic risk prediction. Together, these issues and opportunities highlight the need for new computational approaches that can scale to multiple populations and large-scale molecular phenotype catalogues while accounting for underlying heterogeneity and shared signals. Here, we propose novel approaches to integrate GWAS data from multiple populations and phenotypes to characterize the population-specific and shared evolutionary architectures. Importantly, our approaches run directly on summary data, which enables immediate large-scale analysis. We propose to apply our novel approaches to large-scale multi-population GWAS data. Together, our work will systematically characterize evolutionary architectures for complex diseases and molecular phenotypes and populations in a robust, open, and reproducible approach.

Public health relevance
Many genetic variants have been associated with common complex diseases, but the evolutionary and functional architectures that shape genome-wide risk are still unclear. Recent efforts to characterize the extent to which natural selection and functional genomic features determine genetic risk have primarily targeted complex disease in single populations, which substantially limits the potential to understand disease etiology. Here, we develop and apply novel scalable computational approaches characterize the evolutionary and functional architectures in multiple populations and phenotypes to elucidate the mechanisms mediating risk for complex disease. Modified B1/B6 of RPPR B.1 WHAT ARE THE MAJOR GOALS OF THE PROJECT? The goals of this grant are: Aim 1. To characterize the evolutionary architecture of complex traits and diseases by developing novel multi-population functional- and evolutionarily-informed methods. In (1A) we will develop a novel approach to infer the evolutionary architecture in a multi- population setting using individual- or summary-level data with functional genomic annotations that are robust to population stratification and other common causes of confounding in selection-based GWAS inference. In (1B) we will develop the first approach, to our knowledge, inferring the evolutionary architecture for admixed individuals using individual-level data together with relevant functional genomic annotations. In (1C) we will develop novel, robust statistical approaches to test for evidence of polygenic adaptation across populations. Aim 2. To identify core disease genes and pathways by developing novel approaches for studying selection on molecular phenotypes. In (2A) we will develop novel, scalable approaches to infer the landscape of evolutionary architectures jointly across diverse molecular and allele-specific phenotypes using individual-level data. In (2B) we will integrate cutting-edge single-cell perturbation experiments with population-scale data to identify core disease genes for which selection has purified common causal variants. To understand how selective pressure on molecular phenotypes translates to complex disease in (2C) we will develop novel approaches estimating the fraction of disease heritability that is causally mediated by molecular phenotypes under selection using GWAS summary data. Aim 3. To improve polygenic risk prediction by developing selection-aware approaches. To improve the transferability of polygenic risk scores, in (3A) we will develop novel selection-aware approaches to PRS construction leveraging GWAS summary statistics together with functional genomic annotations. To increase the accuracy of TRS construction, in (3B) we will develop a novel TRS gene-weighting procedure based on our selection models of molecular phenotypes. In (3C) we will broadly apply our approaches to the Metabolic Study in Men (METSIM) to understand the role of selection in shaping molecular phenotype risk for complex disease. B.6 WHAT DO YOU PLAN TO DO DURING THE NEXT REPORTING PERIOD TO ACCOMPLISH THE GOALS? For year 5 we plan to continue with methods development for Aims 1, 2, & 3. Specifically, we plan to: 1. Publish manuscripts currently preprinted and in review, 2. Pre-print manuscript on stabilizing selection in molecular phenotypes using highly scalable and differentiable discrete time Wright Fisher simulations, 3. Pre-print manuscript on inferring MAF-dependent architectures for complex trait and diseases observed in admixed individuals. As done for our previous preprinted and published approaches, we will continue to use extensive simulations based on realistic genetic data (e.g., 1000 Genomes.) to thoroughly demonstrate the validity and robustness of our methods. We plan to use All of Us research portal to apply our approaches when applicable. We do not plan to modify our aims.